OTHER FUNCTIONS: CELL-FREE PRODUCTION OF SITE-SPECIFICALLY PHOSPHORYLATED PROTEI

SBIR Topic 312 Generation and Qualification of site-specific Post-translationally Modified Proteins for Use as Calibrators in Pharmacodynamic (PD) Assays